Connecting Women to Care: Home-based Psychotherapy for Women with MST Living in Rural Areas

Background – Military Sexual Trauma (MST) among women Veterans is a problem of epidemic proportion
associated with significant mental health and functional impairment and substantial access to care barriers.
Surveillance data indicate that one in four women Veterans reports MST when screened. Compared to women
Veterans with other service-related stressors, those experiencing MST have greater mental health problems,
are more likely to report difficulty in functioning in social, family and intimate relationships and are more likely to
be unemployed and to report difficulties in finding a job. Nevertheless, women with MST engage less
frequently in VA health care than other women Veterans. Barriers to care include distance from specialty
services, financial difficulties, childcare and family responsibilities, and gender-related discomfort in male-
dominated VA facilities. Research over the past decade has identified the problems and concerns of women
Veterans with MST but programs addressing their mental health needs and responsive to identified barriers
are lacking. The proposed study addresses this gap by evaluating a gender-sensitive, evidence-based skills
training program delivered via home-based video technology.
Specific Aims – The study will conduct a Hybrid Type 1 effectiveness-implementation study to accomplish two
aims. The first is to determine the effectiveness of the HBVT-delivered, Skills Training in Affective Regulation
(STAIR) relative to a HBVT-delivered nonspecific active comparator, Present Centered Therapy (PCT) among
women Veterans with MST. It is hypothesized that STAIR will be superior to PCT in regards to improvement in
CAPS PTSD symptoms (primary outcome) as well as in perceived social support and social engagement
(secondary outcomes). The second aim is to conduct a multi-stakeholder, mixed method evaluation to inform
future potential implementation plans by identify barriers and facilitators of implementing STAIR via HBVT and
to contextualize and interpret the quantitative data on treatment processes and clinical effectiveness.
Methodology – This is a four-year, two-site Hybrid Type 1 effectiveness-implementation study design. A total
of 200 women Veterans with MST and PTSD symptoms (with DSM-5 PTSD Screen cut-off > 3) will be enrolled
into the study. Participants will be stratified by rurality status in a proportion representative of the national
population (34% rural vs. 66% nonrural). Stratification will ensure that resources are dedicated to recruit the
identified number of rural women. Within each level of stratification, participants will be randomized into one of
two treatments conditions, STAIR or PCT, each of which is comprised of 10 weekly sessions. Assessments will
be conducted at five time-points: baseline (week 0), midtreatment (week 5), immediately posttreatment (week
10), 2-month follow-up (week 18) and 4-month follow-up (week 26). Rurality will be included as a covariate and
assessed for variations in aspects such as retention and outcome, which will help inform future implementation
plans. Multi-stakeholder mixed-method process evaluation concerning STAIR and the use of in-home delivery
of services will include administrator, clinician and patient stakeholders. Expected Results and Anticipated
Impacts on Veterans Healthcare – It is expected that the proposed study has the potential to improve the
quality of VA healthcare by establishing the effectiveness of a social skills intervention, Skills Training in
Affective and Interpersonal Regulation (STAIR) delivered via home-based video technology (HBVT) to women
Veterans with MST, particularly those living in rural areas. The treatment simultaneously addresses social
concerns and PTSD symptoms, both of which are identified needs of women Veterans who have experienced
MST. STAIR has been demonstrated as efficacious in community populations and pilot data with women
Veterans with MST indicate similar outcomes regarding improvements in perceived social support, social
engagement and PTSD symptoms. The use of HBVT has the potential of increasing access to care to this
geographically dispersed and underserved population.

Public health relevance
Military sexual trauma (MST) is a common duty-related stressor which occurs among one in four female Veterans and is associated with substantial concerns about social isolation and high rates of PTSD. Women with MST also experience numerous person-level barriers to care including the desire to avoid male-dominated VA clinics, transportation difficulties and childcare responsibilities. Treatment programs that address the social and mental health needs of this population and acknowledge barriers to care that disproportionately affect women are lacking. The proposed study will use a hybrid effectiveness-implementation design to evaluate the in-home delivery of a gender-sensitive, evidence-based coping skills program to improve social and role functioning as well as reduce PTSD and will prioritize enrolling rural women in a representative manner. If the program is found to be successful at improving social functioning and PTSD, and in reducing barriers to care, it will provide a tremendous benefit to women Veterans with MST, particularly those in rural areas.